Metabolic Regulation by SAPS3 of Virus-specific T cell Immunity

PROJECT SUMMARY
Chronic infections like HIV, HBC and HCV and cancers that evade the immune system continue to impact the
lives of millions of patients worldwide causing high morbidity and mortality. It is now evident that during persistent
antigen, CD8+ T cells become phenotypically and functionally exhausted. Continuous TCR stimulation, high
expression of multiple inhibitory receptors, and multiple immunosuppressive mechanisms limit effector T cell
functions. T cell exhaustion is observed in chronic infections in murine, monkey, and human hosts. Immune
checkpoint blockade (ICB) can reinvigorate exhausted T cells and improve pathogen and tumor control in mice
and patients. These drugs are now standard treatments for cancer, but at present are effective only in very few
patients, highlighting the need to identify additional immunotherapies aimed to enhance the quality and quantity
of the responding T cells to help improve patient outcomes. Our previous findings have identified
Serine/threonine-protein phosphatase 6 (PP6) regulatory subunit 3 (SAPS3) as a negative regulator of AMPK.
Preliminary data reveal that SAPS3 is highly expressed and upregulated on exhausted CD8+ T cells during
infection. Mice with SAPS3 deletion exhibit increased frequencies and numbers of virus-specific CD8+ and CD4+
T cells, with enhanced functionality and increased mortality compared to wild-type (WT) mice following Cl13
infection. In addition, we found that inhibitor receptors were lower on virus-specific CD4+ and CD8+ T cells in
Saps3-/- mice. Mechanistically, we observed increased AMPK activity and metabolism in Saps3-/- CD8+ T cells
compared to WT only after Cl13 infection. Our data also showed that after acute LCMV Arm infection, Saps3-/-
mice develop higher frequencies and numbers of functional CD8+ T cells. Based on our preliminary data, we
plan to test the central hypothesis that SAPS3 is a key negative regulator of CD8+ T cells through regulation of
AMPK and metabolism during chronic viral infection. The proposed research will provide a mechanistic analysis
of how T cells are regulated during viral infection. We will test our hypothesis by pursuing the following three
specific aims 1) To determine the role of SAPS3 in virus-specific T cells during acute and chronic viral infection
2) To elucidate the molecular mechanisms by which SAPS3 regulates T cell activation 3) To evaluate the
therapeutic potential of combining Saps3 deletion and immune checkpoint blockade (ICB) in therapy sensitive
vs resistant tumors. This contribution will be significant because understanding how metabolic regulators
fundamentally function in T cells has the potential to lead to the development of therapeutic interventions
targeting these pathways to modulate T cells and help prevent and/or treat patients with chronic infection, cancer,
or autoimmunity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because discovering how T cells differentiate during viral infections and is anticipated to increase our understanding of pathways that modulate the immune response to these diseases. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to development of fundamental knowledge and therapeutics to help reduce the burdens of patients afflicted with chronic viral infections.